The novel role of Sirtuin 2 in regulation of transcription-associated DNA damage repair

Project Summary
The consequences of irradiation- and/or Cisplatin (IR/CisP)-induced neuronal toxicity,
i.e., neurological function deficits, often irreversible and permanent, represent a daunting
challenge when treating patients with cancer. The underlying mechanisms of toxicity remain
poorly understood and the ability to selectively protect neuronal survival while not compromising
tumor control following IR/CisP is lacking. This proposal aims to determine the mechanisms
protecting neurons from IR/CisP-induced cytotoxicity, with the overarching goal to provide
evidence supporting novel strategies to decrease their neurotoxicity, while maintaining therapy
efficacy and improving patient quality of life. NAD+-dependent deacetylase sirtuin 2 (SIRT2),
which is highly expressed in differentiated neurons, is involved in diverse cellular processes
including metabolism, response to oxidative stress, and tumor suppression. Our preliminary study
has discovered a novel signaling network that connects SIRT2 to transcription coupled-
homologous recombination repair (TC-HRR) and -nucleotide excision repair (TC-NER) of DNA
damage and neuronal cell resistance to IR/CisP-induced cytotoxicity. Furthermore, our data
revealed that CSB, the key mediator for TC-HR/TC-NER, is directly deacetylated by SIRT2.
Moreover, the cyclin-dependent kinase 5 (CDK5), which is involved in DNA damage signaling in
neuron cells, phosphorylates and inhibits SIRT2 function in DNA repair and neuronal survival
following IR/CisP. We hypothesize that SIRT2 activity, which is suppressed by CDK5-mediated
phosphorylation, protects neurons against IR/CisP-induced DNA damage by enhancing CSB-
directed TC-NER and TC-HRR, thereby attenuating neuronal cytotoxicity and neurological
deficits. A series of in vitro and in vivo experiments are proposed to test this hypothesis: Aim 1
will determine whether CSB mediates SIRT2 promotion of TC-NER/TC-HRR and neuron survival
following IR/CisP. Aim 2 will determine how CDK5 negatively regulates SIRT2 function in TC-
NER/TC-HRR and neuron survival following IR/CisP. Aim 3 will test if pharmacologically targeting
SIRT2 specifically attenuates neuronal deficits following IR/CisP-based cancer therapy. Results
from these studies will provide insights into the biological role of SIRT2 and the molecular
mechanisms regulating the repair of IR/CisP-induced DNA damage. We expect this study to lay
the foundation for future research investigating the targeting of the CDK5/SIRT2-CSB signaling
axis as a novel strategy to alleviate and/or prevent neurotoxicity in cancer patients who need
IR/CisP therapy.

Public health relevance
Project Narrative The consequences of irradiation- and/or Cisplatin (IR/CisP)-induced neurotoxicity, often irreversible and permanent neurological deficits, represent a daunting challenge when treating patients with cancer. This proposal aims to determine the mechanisms protecting neurons from IR/CisP-induced cytotoxicity, with the overarching goal to provide evidence supporting novel strategies to decrease their neurotoxicity, while maintaining therapy efficacy and improving patient quality of life. We expect this study to lay the foundation for future research investigating the targeting of the CDK5/SIRT2-CSB signaling axis as a novel strategy to alleviate and/or prevent neurotoxicity in cancer patients who need IR/CisP therapy.